Make Play Safe: Intervention to Increase Concussion Recognition and Reporting in Youth Soccer

PROJECT SUMMARY
Sports-related concussions (SRCs) affect nearly two million US children annually, posing significant acute and
long-term risk to the developing brain. The actual number of SRC incidents is likely higher, as up to one-third go
unreported. Most existing SRC education and prevention programs transmit knowledge effectively but fail to
change reporting behaviors, leaving youth athletes failing to recognize or report sports-related concussions
(SRC). Innovative approaches to improve SRC reporting behaviors among youth athletes are urgently needed.
The proposed intervention, Make Play Safe (MPS), is a two-component program grounded in behavioral theory
aimed at enhancing SRC recognition and reporting among youth soccer athletes. MPS leverages virtual reality
(VR) technology to allow youth athletes to virtually “experience” SRC events and symptoms. It also provides
effective communication strategies for parents and coaches to facilitate and enhance discussions about SRC
reporting and safety. The long-term goal of this project is to reduce negative and potentially long-lasting SRC-
related health consequences by increasing SRC reporting among youth athletes. Specifically, this study will
determine if the MPS intervention increases soccer athletes’ SRC recognition and reporting intentions (Aim 1)
and SRC reporting behaviors (Aim 2). Additionally, it will evaluate whether the efficacy of the MPS intervention is
mediated by the frequency of parent-child or coach-team communication about SRC (Aim 3). Boys’ and girls’
soccer athletes aged 9-12, along with their parents and coaches, will be recruited from eight youth recreational
soccer leagues in central Ohio (n = 960 athletes, 960 parents, and 64 coaches) and enrolled in four waves. In
each wave, two of the eight leagues will be randomly selected and assigned to either the Intervention or Control
group. The intervention includes a VR-based SRC education session for youth soccer athletes at the beginning
of the season and a weekly message notification program for parents and coaches throughout the season.
Both groups will also receive the standard SRC education currently provided by their soccer league. Study out-
come assessments will be conducted with athletes, parents, and coaches pre-season, during the season, post-
season, and six months after the season ends. This project is significant because it addresses the underreporting
of SRC in youth soccer, a popular sport for both boys and girls with a high rate of SRCs. The project is innovative
in its use of VR technology to interactively teach youth athletes about SRCs in a safe and distraction-free, yet
realistic environment. The findings of this study will have a significant impact, as the intervention is theory-driven,
developmentally appropriate, and readily scalable for wide dissemination and immediate use at minimal cost
by youth sports organizations, schools, and community groups. When adopted, this intervention has the poten-
tial to vastly improve youth athletes’ SRC recognition and reporting behaviors, thereby reducing the negative
and long-lasting health consequences.

Public health relevance
PROJECT NARRATIVE Most existing sports-related concussion (SRC) education programs effectively transmit knowledge but often fail to change behaviors, resulting in many youth athletes not recognizing or reporting SRCs. The proposed two- arm, cluster randomized controlled trial will evaluate the efficacy of Make Play Safe, a novel, theory-driven, virtual reality simulation-based SRC education intervention designed to help boys’ and girls’ soccer players aged 9-12 recognize and report future SRCs. This project aligns with the NIH’s mission to positively impact the health of youth athletes, ensuring they recognize, report, and seek immediate treatment for concussive injuries, thereby preventing potential long-term health consequences.